PARP-1 Degradation for PARP-Related Diseases

Project Summary/Abstract
This trans-disciplinary research proposal focuses on developing a novel class of PROteolysis
TArgeting Chimeras (PROTACs) aimed at degrading Poly (ADP-ribose) polymerase-1 (PARP-1)
activity in diseased human cells. PARP-1, one of the most abundant nuclear proteins, plays a
pivotal role in responding to cellular stress, particularly DNA damage, through both enzymatic and
scaffolding functions. Its enzymatic activity involves poly (ADP-ribosyl)ation (PARylation) of itself
and key downstream substrates in the DNA damage response (DDR) pathway, facilitating the
recruitment of DNA repair factors. Once PARylated, PARP-1 dissociates from DNA, allowing
normal cellular processes to resume. Dysregulation of PARP-1 is implicated in various diseases,
including neurodegenerative disorders (e.g., Alzheimer’s, Parkinson’s), inflammatory conditions
(e.g., arthritis, multiple sclerosis, colitis), and several cancers, making it a high-priority target for
therapeutic intervention. While PARP-1 inhibitors (PARPi) have achieved clinical success, with
four FDA-approved for oncology, their mechanism frequently results in PARP-1 trapping at DNA
repair sites, leading to cytotoxicity in normal cells. Moreover, resistance to PARPi remains a
significant clinical hurdle. To address these challenges, this proposal aims to develop a new class
of PARP-1 degraders that downregulate PARP-1 activity, effectively mimicking genetic ablation.
Our approach involves designing a focused library of PROTACs utilizing highly selective, single-
digit nanomolar PARP-1 inhibitors based on a novel benzoimidazole-4-carboxamide chemotype,
coupled with cereblon E3 ligase ligands (Aim 1). These PROTACs will be evaluated in cellular
models to confirm their time- and dose-dependent efficacy in degrading PARP-1 (Aim 2).
Preliminary data support the feasibility of this strategy. In addition to advancing the field of targeted
protein degradation, this project will offer valuable hands-on research experience in medicinal
chemistry, computational modeling, enzymology, and cell biology to both undergraduate and
graduate students. Moreover, successful outcomes from this collaboration will enhance the
research capacity and scientific environment at Queens College.

Public health relevance
Project Narrative The aberrant function of PARP-1, an important cellular enzyme, has been associated with a wide variety of human diseases, including multiple sclerosis, Parkinson’s and Alzheimer’s diseases, arthritis, diabetes, and cancers. In this research proposal, novel PROTAC degraders will be developed to mitigate the aberrant function of the PARP-1 enzyme in diseased cells. This will expedite therapeutic drug development efforts targeting the PARP-1 enzyme and improve human health.